Association between adverse maternal factors and neurodevelopmental outcomes among children in Kenya

ABSTRACT
More than half of Kenyan children under 5 years (~4 million Kenyan children) will not reach their developmental
potential, a pathway partly determined by modifiable maternal risk factors such as stress, infection, and
inadequate nutrition in pregnancy and lactation. Maternal factors such as older age, anemia, poor nutrition, HIV
infection and depression have been associated with adverse effects on child neurodevelopment, although the
quality and strength of the evidence varies. Data on the relationship between maternal factors and human milk
oligosaccharides (HMOs), one of the most abundant bioactive molecules in human milk, are all from high-income
settings, where the composition of HMOs differs by maternal age, nutritional status, depression, and HIV
infection. Limited data exists on the influence of HMOs on child neurodevelopment, including in Sub-Saharan
Africa. HMOs and maternal factors may act independenly to influence child neurodevelopment. It is plausible
that the maternal factors may impact HMO profiles, and, in turn, influence child neurodevelopment. The
proposed F32 research project leverages data from an ongoing cohort ongoing cohort of Kenyan mother-infant
pairs (N=350) (Tunza Mwana R01HD096999; 1P01HD107669-01) followed up for 2 years from birth to evaluate
the association between maternal HIV infection, milk composition, and the infant gut microbiome, and
characterize infant growth and neurodevelopment at 24 months of age. In Aim 1, we will determine how adverse
maternal factors in pregnancy (older age, depressive symptoms, anemia, HIV infection, and nutritional status)
affect HMO composition at 6 weeks postpartum. In Aim 2, we will determine the association between adverse
maternal factors in pregnancy and child neurodevelopmental outcomes at 2 years of age. Finally, in Aim 3, we
will assess if HMOs mediate the relationship between adverse maternal factors in pregnancy and child
neurodevelopment at 2 years of age. This project will provide new insights on modifiable maternal factors and
child neurodevelopment in Sub-Saharan Africa region, and inform ways to prevent or reverse the
neurodevelopmental consequences of adverse maternal environment by highlighting the potential mechanisms
of neurodevelopmental impairment. The research plan will provide the F32 candidate rigorous postdoctoral
training including training in 1) child neurodevelopmental assessment and research 3) content area expertise in
breastmilk research 3) advanced statistical methods of epidemiologic research 4) strengthen publication record
and communication skills.

Public health relevance
PROJECT NARRATIVE An estimated 53 million children under five years of age have developmental disability with 95% of these children living in low- and middle-income countries. This project leverages data from an ongoing R01 aimed to characterize the human milk components, and infant gut microbiome, growth and neurodevelopment in Kenya. The proposed aims will address gaps in knowledge of influence of maternal factors on child neurodevelopment, with an important focus on the varying breastmilk composition by maternal factors and provide the F32 candidate with the opportunity to acquire new methods and scientific expertise and develop necessary skills to become independent researcher.